IMMUNE RECONSTITUTION FOLLOWING BONE MARROW TRANSPLANT FOR IMMUNODEFICIENCY

Immune reconstitution after bone marrow transplantation will be followed to determine the events which correlate with good or poor results.